Role of insulin-like growth factor binding proteins in the pathogenesis of herpes stromal keratitis.

Herpes stromal keratitis (HSK) is a chronic inflammatory condition that develops in response to a recurrent
corneal infection with herpes simplex virus-­1 (HSV-­1). HSK is the leading cause of infection-­induced corneal
blindness in the United States. Clinical manifestation of HSK involves the development of opacity and
neovascularization into the avascular cornea. Newly formed leaky blood vessels in the corneal stroma obscure
the visual axis, traffic the leukocytes (mostly neutrophils) into the inflamed cornea, and cause the corneal edema.
The current mainstay of HSK treatment requires the long-­term use of oral antiviral drugs and the topical
application of steroids. The prolonged use of topical steroids causes a predisposition to herpetic reactivation,
cataract development, and increased intraocular pressure (IOP), which may cause the development of
glaucoma. A better understanding of cellular and molecular events involved in the pathogenesis of HSK could
provide novel therapeutic targets to reduce the severity of HSK. The focus of this application is to understand
the mechanisms by which Insulin-­like growth factor binding protein-­3 (IGFBP-­3) regulates the pathogenesis of
HSK. IGFBP-­3 exerts its effect through insulin-­like growth factor (IGF)-­independent and-­dependent mechanisms.
In an IGF-­independent manner, IGFBP-­3 is known to induce cellular senescence. The cellular senescence is
reported to inhibit viral replication. The IGF-­dependent activity of IGFBP-­3 involves sequestration of IGF-­1 and
IGF-­2 molecules and limiting their bioavailability to IGF-­1R, and thereby regulates IGF-­1R signaling. Our
preliminary results showed an elevated expression of IGFBP-­3 in HSV-­1 infected corneas of B6 mice, whereas
a significantly reduced amount of IGFBP-­3 protein was detected in the circulation of infected B6 mice when
compared to uninfected B6 mice. The infected corneas of IGFBP-­3 knockout (IGFBP-­3 KO) mice showed an
increased viral load. Besides, increased phosphorylation of IGF-­1R, the first step in IGF-­1R signaling, was
determined in leukocytes infiltrating the HSK developing corneas of IGFBP-­3 KO than B6 mice. A significant
increase in hemangiogenesis and opacity was measured in infected corneas of IGFBP-­3 KO than B6 mice.
Together, these results led us to hypothesize that IGFBP-­3 enhances viral clearance, reduces angiogenesis,
and decreases the survival and effector function of myeloid cells in HSK developing corneas. Therefore,
enhancing the IGFBP-­3 protein level in HSV-­1 infected cornea should alleviate the severity of HSK. Three aims
are proposed to test our hypothesis. Aim I will test the hypothesis that hypoxia enhances IGFBP-­3 expression
in corneal epithelial cells, and an increased level of IGFBP-­3 induces senescence in epithelial cells, and cellular
senescence promotes HSV-­1 clearance from the infected cornea. Aim II will test the hypothesis that IGF-­1R
signaling in myeloid and vascular endothelial cells control the severity of HSK. Aim III will test the hypothesis
that increasing IGFBP-­3 protein in HSV-­1 infected cornea alleviates the severity of HSK.

Public health relevance
The goal of this application is to determine the underlying mechanisms by which Insulin- like growth factor binding protein- 3 (IGFBP- 3) reduces viral load, hemangiogenesis, and the survival and effector function of neutrophils in herpes stromal keratitis developing corneas.